Substrate-mediated collective cell migration incalvarial bone expansion and disease.

Summary
Congenital defects affecting the formation of the skull roof, such as craniosynostosis or persistent fontanelles,
occur as a result of abnormal calvarial growth and differentiation. We lack a basic understanding of how calvarial
bones grow, which in turn impacts the position, patterning, and fusion of sutures, and thus etiology of these
disorders. The Harris and Atit laboratories have uncovered an unexpected and intriguing role for cellular sensing
of graded fibronectin matrix in preferentially regulating apical expansion of calvarial progenitors during mouse
development. When cellular lamellipodia are inhibited, mouse calvarial osteoblasts fail to appropriately migrate
resembling defects seen when we conditionally delete fibronectin. These findings are bolstered by data that
fibronectin is misregulated in patients with craniosynostosis as well as animal models of this disease. We propose
that graded fibronectin may act as a substrate for coordinated migration of calvarial osteoblast progenitors over
the skull roof. Our central hypothesis is that calvarial growth and suture patency are dependent on
fibronectin-directed calvarial progenitor cell expansion. Through three focused mechanistic and
translational aims, we will directly test this model and hypothesis of fibronectin substrate-mediated migration
underlying a diverse number of cranial pathologies. First, we will assess outcomes of altered fibronectin
expression in regulation of calvarial growth. Second, using newly established genetic lines in mouse and
zebrafish, we will test the dependence on fibronectin adhesion and the role of lamellipodia-dependent cellular
sensing of an extracellular gradient in apical expansion of calvaria. Third, we will capitalize on diverse mouse
models of craniosynostosis to assess commonality of fibronectin disruption in clinically relevant dysmorphologies
and whether decreasing fibronectin expression rescues craniosynostosis in in vivo. Our unique genetic tools in
both mouse and zebrafish will allow us to define the function of fibronectin-guided, lamellipodia-based, collective
cell movement in vivo during calvarial bone expansion and the impact of fibronectin deficiency on suture patency.
Results from these studies will help detail substrate-mediated cell migration of osteoblast progenitors and will
lead to new strategies for targeted therapies of calvarial bone defects and craniofacial disorders.

Public health relevance
Project Narrative The skull roof is an exquisite set of patterned bones that encase the brain and sensory organs of all vertebrates. In humans, calvarial defects such as craniosynostosis, which occur in 1/2500 live births, have detrimental consequences for brain and sensory organ development. The objective of this proposal is to define the role of substrate-based cell migration in regulating normal skull development as a key mechanism underlying craniofacial pathologies.